Abramson Cancer Center Support Grant

PROJECT SUMMARY/ABSTRACT
Pediatric brain tumors (PBTs) are the leading cause of disease-related death in children in the United States,
with low grade glioma being the most frequent diagnosis. The Children’s Brain Tumor Network (CBTN)
represents a multi-institutional data and biosample sharing framework operating a standardized IRB-approved
observational protocol with more than 5,000 enrolled participants and families. Complementing longitudinal
data collection have been large-scale, NCI-sponsored molecular datasets underpinning one of the largest
multimodal pediatric brain tumor cohorts recently released as part of the Childhood Cancer Data Initiative and
the Gabriella Miller Kids First Data Resource, a data coordination center at the Children’s Hospital of
Philadelphia. Despite these successes, challenges still exist for the rapid exchange and use of medical imaging
data, as well as the association of imaging with other data modalities, and there remains the unmet need for
scalable infrastructure to enable predictive analytics with imaging and multi-modal pediatric brain tumor data.
Consequently, the translation of clinically acquired MRIs to research and AI/ML model building for predictive
modeling of PBTs has been limited. The proposed work will establish a cloud-based federated learning (FL)
infrastructure that leverages CBTN’s existing multi-institutional network of >30 hospitals and existing Kids First
Data Resource cloud platforms for imaging, clinical, and genomic data, and implement a multi-modal prediction
framework for progression-free survival risk in pLGG as a proof-of-concept. An open-source, extensible FL
framework will be utilized with data privacy measures and user-friendly workflows for data curation and the
association of subject-level data across modalities. The FL framework will be assessed for stability and
generalizability in the context of real-world healthcare data collected clinically, as well as technical and model
development factors that could potentially limit its broader use. This includes support for federated statistics to
quantitatively characterize dataset heterogeneity between institutions (e.g., differences in data quality due to
site-level imaging and molecular data acquisition protocols). Overall, the project’s goal is to equip research
investigators with the ability to perform multi-institutional data analysis with state-of-the-art federated methods in
a secure, high-computing, high-throughput environment, and minimize the related technical and operational
burdens met by scientific teams. Through these efforts, the community will be better able to bridge advanced
multi-modal analytics with the pediatric neuro-oncology research setting and to ultimately develop personalized
treatments for better outcomes in children with cancer.

Public health relevance
PROJECT NARRATIVE Pediatric brain tumors are the leading cause of disease related death in children; in the proposed project, the Children’s Hospital of Philadelphia, in its role as a data coordinating center for the multi-institutional Children’s Brain Tumor Network consortium and the Kids First Data Resource will establish a secure, cloud-based federated learning infrastructure for the management and analytics of imaging, genomic, and clinical data. The project harnesses existing cloud-based infrastructure and platforms to advance a federated learning (FL) framework that will be used to build a multi-modal predictive model to estimate progression-free survival in pediatric low grade glioma and assess FL as a solution for developing artificial intelligence models with real- world healthcare clinical and imaging data. The overarching goal of this project is to accelerate multimodal data analytics and clinical translation, ultimately providing enhanced data-driven decision support for the diagnosis and clinical care of pediatric brain tumor patients and their families.